Hyperpolarized 129Xe MRI for imaging NK cell therapy of lung metastasis

Abstract. Emerging cell-based therapies may greatly improve therapeutic success of cancer treatment. NK cell
immunotherapy is particularly important in treatment of pediatric cancers, where information on tumor
immunogens is lacking. Recently, there has been increased interest in the use of adoptive transfer of ex-vivo
expanded NK cells for the treatment of solid tumors due to their innate features, higher safety compared to T
cells and lower cost. This emerging therapy is of particular importance in osteosarcoma where 30-35% of patients
die of pulmonary metastases due to a treatment-failure rate of 85% in this patient group. However, an important
problem with implementation of cell therapies in the clinic is our inability to readily assess the presence and
distribution of therapeutic cells after administration. Visualization of immune cell distribution and migration with
non-invasive imaging could offer significant new insight into the progression of immunotherapy between infusion
and invasive biopsy or resection. Although there are a number of viable approaches for imaging of
immunotherapy, all current strategies have limitations and no technology has been proven as a single solution
for longitudinal imaging of cellular immunotherapies. Therefore, it is important to continue pushing the limits of
available imaging tools in order to find solutions that would address the pressing clinical needs. Hyperpolarized
(HP) 129Xe MRI has recently emerged as a promising modality for direct imaging of respiratory function and gas
absorption. Spectral separation between HP 129Xe gas in the airspace, tissue/plasma, and red blood cells permits
quantification of gas absorption and exchange. Further, a few exploratory studies have demonstrated that
chemical exchange saturation transfer (CEST) of HP 129Xe in perfluorocarbon nanodroplets (PFC NDs) can
significantly enhance sensitivity to the presence of PFC ND’s due to a strong chemical shift between 129Xe gas
in PFC and water. We see these developments as a tremendous opportunity to develop clinically translatable
strategy for imaging NK cell therapy in the lungs. Here we propose to develop foundation for HP 129Xe CEST
(hyperCEST) MRI of NK cells in vivo. The secondary goal is identification of imaging biomarkers of functional
HP 129Xe MRI that may provide additional insight into response to cell immunotherapy. We will rely on our
extensive expertise in (i) synthesis and applications of PFC NDs in biomedical imaging including cell labeling,
and (ii) quantitative MRI, multinuclear imaging (13C, 19F, 129Xe) and metabolic imaging. Our hypothesis is that
labeling of NK cells with PFC NDs optimized for 129Xe hyperCEST MRI will not adversely affect their functionality
and will allow non-invasive NK cell monitoring with high sensitivity and specificity in the lungs. At the completion
of these studies we will have a combination of optimized and validated probes for NK cell 129Xe hyperCEST MRI
with corresponding imaging protocols that will provide foundation for further development of this promising
technology towards clinical translation.

Public health relevance
Cell-based immunotherapies have emerged as an exciting new approach to cancer therapy, but they remain limited by an inability to visualize the biodistribution of cells after administration. In this project, we will develop new methods for labeling and imaging Natural Killer (NK) cells that will permit accurate characterization of their biodistribution in the lungs with high sensitivity.